Career Enhancement Program

PROJECT SUMMARY (Career Enhancement Program)
The goal of the Career Enhancement Program (CEP) is to provide training and guidance for academic physician-
scientists, clinician-investigators, and laboratory-based scientists who wish to dedicate their career and research
efforts to translational cancer epigenetics research. To achieve this goal, the CEP will pursue the following
specific aims:
1. Recruit, train, and mentor physicians, scientists, and senior postdoctoral fellows to become excellent
investigators focused on cancer epigenetics translational research.
2. Educate awardees in all the basic principles of cancer epigenetics biology, including molecular, cellular
and systems biology, drug development, pharmacokinetic and pharmacodynamics studies, and basic
principles of biostatistics and bioinformatics.
3. Provide a firm foundation for awardees in the specific area of cancer epigenetics translational and early
clinical research.
These objectives will be achieved through strong mentorship in which awardees will be instructed in the principles
of clinical, basic, and translational cancer epigenetics research. Specific areas of education may include scientific
and clinical methods, biomedical ethics, statistical design and analysis, bioinformatics, biology, biochemistry,
genetics, epidemiology, and other areas relevant to individual projects. Mentorship will include laboratory-based
investigators, clinical-translational investigators, biostatisticians, bioinformaticians and epidemiologists. Mentors
from within the Epigenetic Therapy SPORE, the Van Andel Institute-Stand Up To Cancer Epigenetics Dream
Team, Coriell Institute, the Van Andel Institute, and institutions of PIs and members of the IAB and EAB will
provide the expertise required for the development of strong, productive translational research skills.

Public health relevance
PROJECT NARRATIVE (Career Enhancement Program) The Career Enhancement Program fosters the scientific development of investigators who intend to focus their careers on translational studies of cancer epigenetic therapies. This is achieved by recruiting innovative entry- level scientists to enhance the SPORE’s overall translational research capability, helping these individuals develop intellectual and technical skills required to be productive investigators, and teaching these individuals basic principles of translational research.